Uncovering the Architecture of Metacognition

Project Summary. Metacognition is the ability to reflect on and evaluate one’s behavior. Impaired metacognition
has been proposed as a major symptom for a number of psychiatric disorders such as schizophrenia, depression,
generalized anxiety disorder, obsessive-compulsive disorder, and even substance abuse. Deficits in metacog-
nition have further been found after brain lesions. Such deficits can have severe detrimental effects on patients;
treating them requires insight into the computational and neural substrates of metacognition. However, efforts in
this direction have been hampered by a lack of an overarching framework that can inform computational models
of confidence, the measurement of metacognitive ability, and the investigation of the neural bases of metacog-
nition. This proposal will advance a novel theoretical framework based on the concept of hierarchical noise ar-
chitecture. Perceptual decision making will be used as a model system but the architecture is perfectly general
and expected to apply across all domains of metacognition. According to the hierarchical noise architecture (1)
sensory noise corrupts the decision-level representation of the stimulus thus affecting both the perceptual and
confidence judgments, whereas (2) an additional metacognitive noise corrupts confidence but not the perceptual
judgment. The proposed architecture makes a novel prediction – namely, that higher sensory noise should be
more detrimental to the perceptual decisions than the confidence rating – that is supported by strong preliminary
data. More importantly, this architecture can be used to extract a new, model-based measure of metacognitive
ability with desirable psychometric properties such as being independent from participants’ bias for high or low
confidence. This new measure can therefore be used to examine the effectiveness of treatments on patients’
metacognitive abilities: for example, if a patient with deficiency in metacognition changes her strategy and starts
using high confidence more, the new measure – but not previous measures – will remain unchanged. Beyond
predicting new behavioral phenomena and leading to an improved measure of metacognitive ability, the hierar-
chical noise architecture can also elucidate the neural bases of metacognition. Specifically, the functional roles
postulated by the hierarchical noise model can be linked directly to the functions of large-scale brain networks
and especially the central executive and the salience networks. These links will be established using a variety of
techniques such as causally interfering with different nodes of these networks, correlating metacognitive ability
with the connectivity within these networks, and examining the dynamics of the inter-network communication
during confidence generation. The insights gained by this proposal will have a direct link to work in the clinic by
providing researchers a better tool to assess the metacognitive deficits of patients (including the effectiveness
of proposed treatments) and link such dysfunction to specific brain circuits. This work is thus expected to benefit
patients suffering a range of diseases from schizophrenia to depression to substance abuse.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will elucidate the computational and neural bases of metacognition thus leading to improved assessment and treatment for people with disorders characterized by metacognitive impairments such as schizophrenia, depression, generalized anxiety disorder, and obsessive- compulsive disorder. Thus, the proposal is relevant to NIH’s mission of developing fundamental knowledge that can be applied to reduce the burden of human disability.